Reciprocal Interactions Linking Cognitive Performance, Aβ aggregation, and Transcriptional Processing with Sleep Disruption in an Alzheimer's Disease Model

Sleep/wake disruption in Alzheimer’s disease patients signiﬁcantly aﬀects their quality of life, is a major contributing factor
for institutionalization, and may represent a proximal cause of neurodegeneration and cognitive decline. Aging remains
the biggest known risk factor for Alzheimer’s disease, and poor sleep patterns, which are often associated with aging, can
also increase dementia and Alzheimer’s disease risk. Clinical studies have suggested a bidirectional relationship between
sleep disruption and deposition of β-amyloid (Aβ), a small peptide associated with plaque formation in Alzheimer’s
disease. Exactly how these protein aggregates inﬂuence molecular and cellular mechanisms to aﬀect Alzheimer’s etiology
are incompletely understood but may target changes in transcriptional processing. This study leverages a multifaceted
approach to unravel the complex interactions between aging, transcriptional processing, protein aggregation, sleep
disturbance, and cognitive decline using an APP/PS1 Alzheimer's disease rat model. We aim to investigate these
interactions by incorporating innovative techniques, such as the use of single-chain variable fragments (scFvs) for
evaluating protein oligomerization of Aβ, tau, α-syn, and TDP-43, proteins known to aggregate neurodegenerative
diseases, alongside advanced transcriptomic analyses, to identify diﬀerentially expressed genes and pathways associated
with protein deposition. We propose to integrate complementary RNA sequencing (RNA-seq), whole-transcriptome
sequencing (WTTS-seq), and capped small RNA sequencing (csRNA-seq), to explore the transcriptomic landscape of Tg-AD
and wild-type rats following changes in sleep pressure associated with cognitive decline using the Vibration Actuating
Search Task (VAST) cognitive assay. By integrating these methodologies, we aim to provide a holistic view of cognitive and
molecular predictors in the severity of Alzheimer's disease pathology. The results could provide signiﬁcant insights into the
molecular links between protein aggregation, sleep disturbances, and cognitive impairments, oﬀering avenues for the
development of novel treatment strategies for Alzheimer's disease.

Public health relevance
Molecular and cellular mechanisms that are affected by sleep loss may be linked to changes in protein aggregation and cognitive dysfunction, which in turn, may further exacerbate sleep disruption. Here we explore these reciprocal processes using a combination of genetic, molecular, physiological, and behavioral assays in an Alzheimer’s disease animal model.